Machine-learning based control of functional electrical stimulation

ABSTRACT We request a supplement to enable successful continuation and completion of the project Aims as originally outlined in our funded grant proposal (1 R01 NS102259-01A1). This project involves restoration of upper limb movements in temporarily paralyzed non-human primates using machine-learning control of electrical stimulation of 30 muscles. Unanticipated circumstances led to financial challenges that limit our ability to complete the project. If a supplement is provided, we believe that we can successfully complete the Aims of the project. The supplement would provide funds to cover the costs associated with purchasing, training, implanting, and recording from two additional monkeys

Public health relevance
PROJECT NARRATIVE This application is for a supplement to enable successful continuation and completion of the project Aims as originally outlined in a funded grant proposal. This project involves restoration of upper limb movements in temporarily paralyzed non-human primates using machine- learning control of electrical stimulation of muscles.